Use of Apatinib-nanosponge conjugate to reduce post-radiation induced oral cavity and salivary fibrosis.

DELTAMED LLC is a startup company focused on developing delivery platforms for small
molecule mitigators of fibrosis. Radiation induced fibrosis and lymphedema in head and neck
cancer patients is a painful, debilitating and cosmetically disfiguring late side-effect following
curative (chemo)radiotherapy. Currently, there are no FDA approved curative treatments, only
therapies that mitigate fibrosis. These therapies target the TGFβ1R-p38-MK2 signaling axis that
activate myofibroblasts thus driving fibrosis. Direct inhibition of MK2 can prevent myofibroblast
development and subsequent fibrotic injury. In addition, soft tissue fibrosis in liver, bowel and lung
occurs due to activation of pro-angiogenic signaling processes. We and others have shown that
the small molecule Apatinib prevents MK2 activation. The polypeptide, MMI-0100, is an allosteric
MK2 inhibitor originally designed to disrupt MK2 signaling but MMI-0100 suffers from having an
exceptionally short plasma half-life. Currently, there are no FDA-approved MK2 inhibitors and
early generation small molecule MK2 inhibitors lack “druggability”.
Encapsulation of drug molecules in nanoparticles significantly extends plasma half life by reducing
drug clearance. Thus, DELTAMED LLC proposes to employ a novel nanosponge prodrug delivery
system for the MK2 inhibitors Apatinib/MMI-0100. T o e n a b l e t h i s , t h e c o m p a n y has
teamed with Dr. Gregory Gan (KUMC), a leader in MK2 research and Dr. Stefan Bossmann the
inventor of the novel drug delivery platform referred to as “nanosponge.” The DELTAMED LLC
team will develop a series of small molecule-nanosponge linked compounds that can selectively
release the active moiety target cells with high potency and selectivity.
The immediate goal of this proposal is to use existing MK2 inhibitors and improve their circulation
half-life and potential cumulative drug delivery i.e. to make them more druggable. In this Phase I
STTR, DELTAMED LLC will link Apatinib and/or MMI-0100 to different nanosponge backbones
via amide and esterase cleavable bond. Conjugated compounds will be iteratively developed and
tested using in vitro cell and protein-based screens. Finally, one lead compound will be advanced
to in vivo biologic studies to determine a maximum tolerated dose and pharmacokinetic and
pharmacodynamic distribution.

Public health relevance
DELTAMED LLC is a startup company focused on the treatment of fibrosis associated with radiation. Radiation induced fibrosis and lymphedema in head and neck cancer patients can be a painful, debilitating and cosmetically disfiguring late side-effect following curative (chemo)radiotherapy and there are no FDA approved curative treatments, only therapies that mitigate fibrosis. In this Phase I STTR, DELTAMED LLC propose to evaluate some lead compounds in a novel nanosponge delivery platform, to improve efficacy and safety of fibrosis treatment.